TO-I BUILDING 1021 2ND FLOOR AHU REPLACEMENT

This project will replace the existing Supply Air Handling Unit (AHU)
located on the 2nd floor of building 1021 with a new roof-mounted AHU, to overcome heat loads generated by the 1st floor tunnel washers.